ROLE OF PERIPHERAL IMMUNE-DERIVED MMP8 IN STRESS SUSCEPTIBILITY

ROLE OF PERIPHERAL IMMUNE-DERIVED MMP8 IN STRESS SUSCEPTIBILITY
In this application we will examine how peripheral monocytes interface with the brain to mediate stress
susceptibility (SUS) vs. resilience (RES). We and others have shown that stress mobilizes monocytes in the
periphery by enhancing their proliferation and egress from bone marrow stores into the circulation and the
trafficking them to target tissues, such as the brain. While we know that such effects have been linked to
alterations in complex stress-related behaviors, the mechanisms by which these immune cells communicate with
the brain has been largely unknown. Using single-cell RNA-sequencing along with advanced bioinformatics, we
first defined the cellular and molecular pathways that interface monocytes and the brain during chronic social
defeat stress (CSDS) exposure in mice. We find that CSDS increases matrix metalloproteinase 8 (MMP8)—a
monocyte-enriched matrix metalloproteinase that can remodel the tissue extracellular matrix (ECMs) and
promote blood brain barrier (BBB) permeability —in SUS, but not RES, mice. We further demonstrate that
peripheral MMP8 directly infiltrates the NAc parenchyma to control ECM reorganization. Depleting MMP8
specifically in peripheral immune cells prevented stress-induced social avoidance behavior and alterations in
NAc neurophysiology and extracellular matrix reorganization. Collectively, these data establish a novel
mechanism by which peripheral immune factors can affect central nervous system function and behavior in the
context of stress. Our team is now poised to exploit the many state-of-the-art tools in this application to gain a
fundamentally more complete understanding of how the peripheral immune system can interface with the brain
to control complex stress behaviors. First, we will define exactly how monocyte-derived MMP8 regulates the
BBB and ECM reorganization and cell-type specific neurophysiological changes in NAc. We will also define the
role of peripheral infiltration of MMP8 in NAc on social and non-social reward/reinforcement behaviors. Together
these studies will provide novel insight into the brain-body mechanisms that drive stress susceptibility, with the
ultimate goal of developing novel therapeutics targeting MMP8 to treat stress disorders.

Public health relevance
NARRATIVE Psychosocial stress can profoundly impact bi-directional communication between the immune system and brain. Here, we propose to study how stress mobilizes the innate immune system to increase blood brain barrier permeability and promote deficits in both social and non-social reward/reinforcement by directly regulating neuronal activity in brain reward regions such as the nucleus accumbens.